Immune development in early life (IDEAL) shapes vaccine response, respiratory infectious diseaseand asthma

PROJECT SUMMARY
To date, efforts to define and apply precision endotyping has been limited to studies of adults. However,
immune development in early life (IDEAL) is dynamic and varies between individuals suggesting that
endotypes corresponding to distinct pathophysiological mechanisms will be age-dependent. We propose
therefore a novel approach in which we will study well-defined longitudinal childhood cohorts and use in silico
integrative analyses of existing and prospectively collected data coupled with age-specific human in vitro model
systems to identify agents that redirect IDEAL away from disease endotypes towards those associated with
health. We have selected three clinical endpoints to correlate with systems biology data to identify IDEAL
endotypes: a) vaccine responsiveness, as vaccines are the most important biomedical intervention to
reduce childhood disease; b) respiratory infection which represents the greatest burden of childhood
infectious disease; and c) asthma, an immune-mediated respiratory disease which manifests in
childhood and results in substantial health burden. Each of these endpoints demonstrates substantial
inter-individual variability enabling powerful systems biology tools to extract meaningful correlations. We
will harmonize and study an IDEAL Meta-Cohort (IMC) comprised of longitudinal childhood cohorts
enrolled in North America, Africa and Australasia. Our Clinical Core in Rochester, NY, is nationally
prominent in the study of childhood immune ontogeny. Project (PR) 1 will employ cutting edge, cross-
platform integrative bioinformatics tools to identify endotypes associated with clinical endpoints. PR2, will
apply epigenetic analysis tools to the same samples and translate to host immune parameters the in
silico-derived signatures. In PR3, key endotype-associated biomarkers and pathways will be dissected in
vitro to establish cause and effect and identify agents (e.g., proteins, metabolites, adjuvants, vaccines) that
may redirect IDEAL away from unfavorable endotypes and towards favorable ones. We have optimized
sample-sparing assays to enable systems biology in infants and our published preliminary data
demonstrate feasibility, robust IDEAL, and suggest distinct signatures by clinical status. Our cross-
platform validation and correlation with endotypes correlating with clinical phenotypes will identify
predictive/actionable biomarkers by i) characterizing IDEAL and microbiome in systemic/mucosal
compartments (Overall Aim 1), ii) identifying endotype-specific biomarkers (Overall Aim 2), identifying in
vitro interventions that re-direct IDEAL endotypes towards health (Overall Aim 3). Overall, we will enhance
and accelerate discovery of new approaches to predict and prevent childhood disease.

Public health relevance
PROJECT NARRATIVE Insufficient knowledge of early life immune development limits our ability to optimize vaccines and prevent, detect, and treat conditions such as infection and asthma. To gain insight into how early life immune development impacts vaccine responses, health and disease we will: (a) employ a systems biology approach to comprehensively measures changes in molecules such as proteins (proteomics), metabolites (metabolomics) and the bacteria that live in our gut and nose (microbiome); and (b) use liquid (plasma) and cells from human blood donations to model immunity and responses to potentially protective agents outside the body (in vitro). Identifying molecular patterns (“signatures”) of infant immune development that correspond to vaccine-responsiveness, susceptibility or resistance to respiratory infection and asthma will accelerate discovery and development of tests to better predict the risk of childhood disease and guide the development of medical interventions (e.g., vaccines) to optimize immune development, prevent disease and enhance childhood health.